ESTROGEN RECEPTOR-COREGULATOR FUNCTIONAL INTERACTIONS

DESCRIPTION (provided by applicant): The classical estrogen receptor, ERα, is a ligand-regulated transcription factor important for normal development, homeostasis and reproduction, and consequently, understanding normal and pharmacological regulation of this receptor's activity is of major significance to human health. It is well accepted that the ability of ERα to regulate gene expression is dependent upon the transcriptional coregulators that ligand-bound receptors recruit to their target genes. The silencing mediator of retinoic acid and thyroid hormone receptors (SMRT) coregulator was initially characterized as a corepressor for ERα bound to the selective estrogen receptor modulator (SERM), 4-hydroxytamoxifen (4HT), however, it can stimulate the activity of ERα bound to estradiol (E2) and this established SMRT as a dual coactivator/corepressor for ERα. Recent work demonstrates that the nature of SMRT interactions with ERα depend upon whether the receptor is bound to agonist or antagonist. Moreover, in addition to the well described activation of histone deacetylase 3 (HDAC3) by SMRT, this coregulator can also bind to a histone demethylase that promotes the transcriptional activity of ERα. The overall goal of the proposed work is to define the ability of two SMRT interacting proteins, with activating and repressive activities, respectively, to regulate ERα-dependent gene expression. The planned experiments will use state-of-the-art biological, cistromic and transcriptomic analysis to test whether differences in the nature of SMRT-ERα interactions contributes to the ability of these distinct complexes to bind and/or regulate ERα in a ligand- and gene-dependent manner, and whether the composition or activity of the repressive complexes can be regulated by cellular pathways. Using novel 3-dimensional culture of mammary epithelial cells that maintain steroid responsiveness and mouse models that enable the precise evaluation of the HDAC3 activation activity of SMRT in vivo, the ability of SMRT to regulate ERα transcriptional activity as well as mammary gland development will define the biological importance of SMRT for regulation of ERα responses to both agonists and antagonists in a physiological setting. Together, these planned studies will evaluate the hypothesis that differences in the proteins that SMRT recruits to ERα target genes are critical determinants of the effect of this coregulator on ERα-dependent gene expression. In so doing, the proposed work will provide critical insight into mechanisms of action of SMRT independent of HDAC3, and the contribution of SMRT to ERα regulation in estrogen-dependent disease such as breast cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding and exploiting normal and pharmacological regulation of estrogen receptor activity is of major significance to human health with respect to both preventing and treating estrogen-sensitive pathologies such as osteoporosis and breast cancer, as well as understanding normal estrogen-dependent development and function. Our findings that SMRT is a selective coactivator for estrogen-stimulated ERα transcriptional activity provide evidence that SMRT can function independently of the confines of the SMRT-GPS2-TBLR1-HDAC3 corepressor complex, and suggest that differences in the interaction between this coregulator and the ERα transcription factor, in conjunction with SMRT recruitment of novel histone modifying proteins drives SMRT to perform as a coactivator rather than repressor of ERα transcriptional activity. It is anticipated that a greater understanding of the complex control of ERα function by this dual coactivator/corepressor will provide novel insights into mechanisms that selectively regulate ERα in normal (e.g. tissue selectivity) and pathophysiological scenarios (e.g., breast cancer), and ultimately provide new approaches for identification and characterization of ER-based therapeutics.